EMOTO: Development of a novel electromagnetic tracking technology for otology

Abstract: The Cochlear Implant (CI) is the primary treatment modality for patients with severe to profound
hearing loss, while continual advances in the preservation of intracochlear structures during implantation make
this a viable option for those with residual hearing. Surgical strategies for preserving cochlear function include
atraumatic techniques such as slow and consistent insertions, surgical planning, and avoiding intracochlear
structures through better understanding of insertion trajectory. However, studies have suggested that trauma to
the cochlea during electrode insertion results in damage to delicate inner ear structures, and up to 50% of
patients experience delayed hearing loss following surgery resulting in a diminished quality of life.1 In this
STTR, iotaMotion aims to develop an electromagnetic tracking system small enough to be integrated
into existing hardware and accurate enough to enable trajectory guidance during electrode array
insertions. The anticipated impact of this technology will be to improve short and long-term hearing outcomes
for CI patients by enhancing structural preservation of the cochlea. The project will develop a working
prototype of a new electromagnetic (EM) tracking system (EMOTO) with high accuracy and minimal-footprint
integration into iotaMotion’s robotic-assist CI insertion system (iotaSOFT). The project has three Aims:
Aim 1: Construct an initial prototype. The first stage of development will include a low-power source driver
to power off-the-shelf EM source and sensors attached to the iotaSOFT device. An existing motion calibration
system will be modified, and our proprietary algorithms will be scaled appropriately to accommodate the small
workspace being used. Finally, we will calibrate the source/sensor combination and test the position and
orientation accuracy.
Aim 2: Modify iotaMotion device for magnetic compatibility. The current iotaSOFT device will undergo any
necessary mechanical redesign to optimize the integration of the EMOTO source and sensor for enhanced
performance.
Aim 3: Evaluate the EM system integrated into iotaSOFT. The final Aim will evaluate the tracking accuracy
of the system in a simulated operating room environment. A calibrated phantom will be used in conjunction
with common sources of EM interference to assess the real-world performance of the EMOTO system.
Ultimately, the success of Phase I will allow development of this insertion system to progress to a second
iteration of the design (based on the knowledge gained in Phase I) and further preclinical testing to establish
the efficacy of the device as compared to the current gold standard of EM tracking systems. STTR funding will
help secure additional outside investment and bring us closer to commercializing this much needed technology
for people suffering from disabling hearing loss.

Public health relevance
Project Narrative: Electrode array insertion in cochlear implant surgery remains a significant challenge, with uncontrolled trajectories to the inner ear sharply increasing the risk of iatrogenic intracochlear trauma; although surgical navigation offers potential solutions, its limitations and bulky design have stalled adoption. To address this issue, iotaMotion will develop an electromagnetic tracking system that can be integrated into an existing insertion system to enable surgical navigation with submillimeter accuracy. This STTR Phase I project will develop a working prototype and demonstrate the capability of the system in a laboratory setting; thereby establishing the feasibility for continued development and commercialization to eventually reduce the incidence of residual hearing loss for the millions who are candidates for receiving cochlear implants.